ECOG STATISTICAL OFFICE

The Statistical Office, under the direction of the ECOG Group Statistician, collaborates on the design, monitoring and analysis of all clinical trials conducted by ECOG. The Statistical Office works with the ECOG Data Management Office and together, the two offices comprise the ECOG Statistical Center. The statisticians are involved in all aspects of ECOG's activities and also conduct an active research program.